Early Psychosis Intervention Network (EPINET) Data Coordinating Center

ABSTRACT
This application outlines and describes the Westat Team’s proposed approach to continuing to serve as the
National Institute of Mental Health (NIMH) Early Psychosis Intervention Network (EPINET) National Data
Coordinating Center (ENDCC). The current ENDCC, in partnership with NIMH, successfully collaborated with
eight regional scientific hubs composed of 110 Coordinated Specialty Care (CSC) programs to fulfill the
original design of EPINET by doing the following: establishing a Core Assessment Battery (CAB) of common
measures; creating a harmonized and consolidated set of CAB data across the eight regional hubs for over
5,000 CSC program participants; developing and hosting an Analyst Zone that provides a secure method for
accessing and analyzing the EPINET harmonized and consolidated data set; and submitting the required data
to the NIMH National Data Archive (NDA). The ENDCC also developed additional components beyond the
original EPINET design, including a web-based CAB data collection suite (WebCAB) and a Program Level
CAB (PL-CAB). In the upcoming funding cycle, we will use the structures and processes already developed
and implemented by the ENDCC to refine and expand the role of the ENDCC. The existing ENDCC health
informatics infrastructure will incorporate enhanced data quality and validation processes, as well as expedited
data transmission methods to create a FAIR (Findable, Accessible, Interoperable, and Reusable) dataset
accessible to a wide range of scientific investigators. Next-generation data analytic tools, visualization methods
and techniques, data query approaches, and dashboards will enable data to be turned into relevant program-
and practice-level information. The knowledge gained and the data collected will be used to refine existing data
collection tools and protocols in collaboration with members of the EPINET Research Consortium. Work
initiated by the ENDCC and currently underway on the fidelity and quality of care measures and variables
necessary as the context for participant-level CAB variables will be fully implemented. The ENDCC will expand
on its current success in engaging CSC programs beyond those participating directly in EPINET, including
enhancing the WebCAB data collection system, designed specifically for widespread implementation, to extend
its role to CSC programs with common measures and metrics.

Public health relevance
PROJECT NARRATIVE This project will fund a second iteration of the National Institute of Mental Health (NIMH) Early Psychosis Intervention Network (EPINET) National Data Coordinating Center (ENDCC). In this funding cycle, the project will use structures and processes already developed and implemented by the ENDCC to refine, improve, and expand the center’s role in the context of the newly established EPINET Research Consortium funded in the companion EPINET RFA. Enhancements in informatics infrastructure, data access, analysis and visualization, data collection tools and methods, and data collection systems will create a national data coordinating center for CSC with common measures and metrics to improve the identification, diagnosis, and assessment of, and effective interventions and outcomes for, early psychosis.